Gene Curation Expert Panel for Syndromic Disorders

ABSTRACT
Syndromic disorders account for a large proportion of the rare genetic disorders that impact the pediatric
population, including many conditions with structural birth defects and other congenital anomalies. These
conditions are a disproportionate cause of morbidity and mortality. Accurate molecular diagnosis is important for
medical management, family planning, and engagement in research studies. Next generation sequencing has
driven the pace of discovery of novel genetic syndromes, yet there are marked inconsistencies in the level of
evidence for gene-disease relationships (GDRs) that complicate the application of genetic testing. We have
formed the Syndromic Disorders Gene Curation Expert Panel (SD-GCEP), an international group of disease
experts, gene curation framework experts, and biocurators representing 23 institutions across 5 continents to
thoroughly curate the evidence supporting the relationship of a gene in causing a disease, and to quantify the
strength of that evidence using the framework developed by the Clinical Genome Resource (ClinGen). The SD-
GCEP consists of representatives from major stakeholders including Online Mendelian Inheritance in Man
(OMIM), Monarch Initiative’s Mondo disease ontology, Genomics England PanelApp, PanelApp Australia,
Centers for Mendelian Genomics, diagnostic laboratories (Ambry, Illumina, Invitae), practicing clinical
geneticists, genetic counselors, and rare disease and model organism researchers. In Aim 1, we will perform 68
GDR precurations, curations and recurations representing the most commonly tested syndromic disorders not
within the purview of other GCEPs, which generally focus on a specific organ or pathway. In Aim 2, we will
perform 89 precurations, curations, and recurations for syndromic GDRs identified through clinical exome and
genome sequencing performed by diagnostic laboratories with personnel involved in the SD-GCEP. In Aim 3A,
we will perform 24 precurations, curations, and recurations for newly discovered syndromic GDRs from the
Centers for Mendelian Genomics, as these are of high interest to diagnostic laboratories to determine when
genes should be added to panels and to clinicians to guide clinical diagnosis and management. The SD-GCEP
is highly experienced and collaborative. In Aim 3B, we will continue to accept requests from other GCEPs to
curate 15 GDRs of interest that are beyond the scope of the other GCEP due to the syndromic nature of the
condition. In total, we will perform 196 precurations, curations, and recurations of GDRs for syndromic disorders
over three years. All curations will be performed using the ClinGen Gene Curation Interface and publicly shared
though the ClinGen knowledgebase to improve genetic testing and diagnosis for syndromic disorders and to
highlight where further research is needed.

Public health relevance
PROJECT NARRATIVE Syndromic disorders and structural birth defects account for a large portion of infants and children with rare disease. Given these are very rare conditions, evidence supporting the relationship of the disease with a gene is often lacking, which can make genetic testing for these conditions challenging and imperfect. We bring together a group of experts from over 20 institutions to evaluate which genes cause syndromic disorders in order to improve medical care.